Development of Advanced Analytical Tools Integrating External Datasets with MoTrPAC Data:Utilizing Statistical, Machine Learning, and AI Approaches to Uncover Molecular Mechanisms of Physical Activity

PROJECT SUMMARY/ABSTRACT
The molecular mechanisms driving physiological adaptations to exercise remain insufficiently understood, despite their
critical role in promoting human health. The Molecular Transducers of Physical Activity Consortium (MoTrPAC) has
generated an extensive multi-tissue transcriptomic dataset from Fischer rats undergoing endurance training, offering an
unprecedented opportunity to investigate systemic responses to physical activity (PA). However, current analytical methods
fall short in capturing the complex regulatory programs that operate across tissues, timepoints, and species, limiting
translational insights into human biology.
This project introduces a transformative computational framework leveraging GeneCompass, a state-of-the-art foundational
model pretrained on over 100 million human and mouse single-cell transcriptomes. GeneCompass integrates diverse
biological knowledge, including promoter sequences, transcription factor binding sites, and gene regulatory networks, to
create biologically informed embeddings that enable precise cross-species comparisons. We will extend and fine-tune
GeneCompass to analyze MoTrPAC’s rat RNA sequencing data, bridging molecular adaptations in rats to human biology.
By aligning orthologous genes across species, this approach will uncover conserved transcriptional regulators and pathways,
revealing shared mechanisms of exercise-induced adaptations.
Our project focuses on three key aims: adapting GeneCompass for multi-species transcriptomic analysis, performing high-
resolution tissue- and timepoint-specific regulatory analyses of PA-induced adaptations, and translating findings from rat
models to human health using cross-species comparisons and in silico perturbation experiments. These efforts will produce
innovative computational tools, dynamic molecular models, and actionable regulatory maps that enhance the value of
MoTrPAC data. By providing a systematic framework for understanding the molecular underpinnings of exercise, this
research will inform precision medicine and support the development of evidence-based strategies to improve human health
through physical activity.

Public health relevance
RESEARCH NARRATIVE This research develops biologically informed computational frameworks, known as foundational models, to analyze MoTrPAC transcriptomic data. Adapted to integrate prior biological knowledge, these advanced machine learning tools enable precise translation of findings from rat models to human biology, uncovering conserved pathways and regulatory networks. This work advances our understanding of molecular adaptations to exercise, offering insights to support strategies for improving systemic health.